Information Technology Services and Support for DCCPS

This contract provides information technology service and support for the Division of Cancer Control and Population Sciences located within the National Cancer institute.